Defining the mechanisms underlying the mammalian kinetochore's structural integrity under force

Project Summary/Abstract
At cell division, the cell must accurately segregate its chromosomes to its two daughter cells. The
kinetochore connects spindle microtubules to chromosomes and plays both physical and biochemical roles: it
must resist and transmit microtubule forces to move chromosomes, and process microtubule signals to control
cell cycle progression. Errors in these processes can lead to disease and birth defects.
The mammalian kinetochore consists of ~100 protein species, with innermost kinetochore proteins
binding DNA and outermost ones binding microtubules ~100nm away. Parallel protein linkages connect DNA
and microtubules. While much is known about the mammalian kinetochore’s architecture, molecular composition
and biochemistry, much less is known about its mechanics. Yet, the kinetochore has a key mechanical function
– segregating chromosomes – and spends much of its life under force. To what extent and how the mammalian
kinetochore maintains its structural integrity under force remain unclear. A major challenge has been in
measuring kinetochore structure in live cells, under different cellular forces, given the kinetochore’s small size
and rapid movements. Our recent approach development measuring inner and outer kinetochore shape changes
with high spatiotemporal resolution in vivo during normal mitosis brings this question within reach.
Here, I propose to test physical and molecular models for how mammalian kinetochores maintain their
structure under spindle forces at metaphase. I will do so using super resolution live imaging and computational
shape analysis of inner (CENP-A) and outer (Hec1) kinetochore proteins in PtK2 cells. In Aim 1, I will test the
hypothesis that centromere stability contributes to kinetochore structural maintenance. I will do so by decreasing
centromere stiffness genetically using an inducible Condensin II knock out cell line and measuring the impact on
resulting kinetochore deformations. In Aim 2, I will test the hypothesis that lateral reinforcement between parallel
kinetochore protein linkages contributes to kinetochore structural integrity. I will do so by replacing an inner
kinetochore protein with a mutant which disrupts crosslinking between parallel linkages, and also by inducing an
acute, partial loss of this candidate protein. In Aim 3, I will test the hypothesis that incorrect, merotelic
attachments give rise to the most dramatic kinetochore deformations at metaphase. I will do so by enriching for
merotelic attachments and asking if more kinetochores then take on large deformations.
Together, this work will help define the mechanisms underlying mammalian kinetochore structural
maintenance (Aim 1 and Aim 2) and the impact of incorrect attachments on kinetochore structure (Aim 3).
Looking forward, this will help us elucidate how the kinetochore’s functions emerge from its structure, and how
its malfunctions can emerge from structural failures. Through this work, I will get training in cellular biophysics,
computational image analysis, molecular approaches, and how to rigorously answer questions, mentor and
communicate science. These will help me towards my goal of being a group leader in industry or academia.

Public health relevance
Project Narrative During cell division, the cell must accurately segregate its chromosomes to its two daughter cells and errors in this process can lead to birth defects and diseases such as cancer. The kinetochore is essential to ensuring that force is transmitted from spindle microtubules to move chromosomes, and here we ask how the kinetochore can do so under high forces without structural failure. This work will provide insight into the structural engineering principles underlying the kinetochore’s robust structure and function, and in the long run inform on possible failures linked to disease.